Sweet receptor T1R3 in airway glucose homeostasis and chronic rhinosinusitis

PROJECT SUMMARY: Human nasal ciliated cells express taste family 1 (T1R) sweet taste receptors that
activate a unique and uncharacterized signaling pathway that regulates glucose uptake across their apical
membrane. Activation of cilia T1Rs leads to arrestin-dependent signaling that increases expression of apically
localized GLUT2 and GLUT10 to lower airway surface liquid (ASL) glucose. Uptake of glucose by airway
epithelial cells is necessary to keep ASL glucose low to limit pathogen growth. During hyperglycemia or during
epithelial barrier breakdown with inflammation, too much glucose leaks into the ASL, which is associated with
increased risk of respiratory infections, particularly Staphylococcus aureus infections. We found that nasal
secretion glucose is high in patients with chronic rhinosinusitis (CRS), which we initially attributed to
inflammation. However, increased ASL glucose in CRS is not reduced by corticosteroids, suggesting other
mechanisms are involved. Several polymorphisms in the TAS1R genes encoding T1R receptors are linked to
CRS risk. We hypothesize that TAS1R polymorphisms affect ASL glucose or CRS patient outcomes. We also
hypothesize that activation of T1R sweet receptors in the airway, using sugar analogues or artificial
sweeteners available from food science, may enhance local innate immunity by lowering ASL glucose to help
the body eradicate infections without the need for conventional antibiotics.
Our goal is to elucidate T1R cilia signaling and impacts on inflammatory airway disease using both lab
(Aim 1) and clinical (Aim 2) approaches. CRS will be our model inflammatory airway disease, because of its
prevalence and public health impact but also because of our ability to analyze hundreds of patients during this
project. In lab, we will use primary human cells cultured and differentiated at air liquid interface to define T1R
signaling and downstream effects. We will use live cell imaging of cilia-localized fluorescent biosensors,
pharmacology, protein knockout/knockdown, and biochemical approaches. We will also use proximity ligation
and mass spec proteomics to identify interacting partners of T1Rs in cilia. In clinic, we will examine how TAS1R
polymorphisms, T1R expression, and/or sweet taste intensity are associated with nasal glucose levels, CRS
symptoms and outcomes, and S. aureus host-pathogen interactions. We will genotype and follow hundreds of
patients and also use cells from these patients in laboratory assays in a multi-PI scientist/clinician approach.
We hypothesize that T1Rs in airway ciliated cells are important and novel therapeutic targets for airway
diseases to keep ASL glucose levels low in patients with diabetes or airway inflammation. Understanding cilia
T1R chemosensation and the unique signaling pathways involved will shed light on how to leverage these
receptors for therapeutic benefit. The independent yet inter-related aims will examine important chemosensory
functions of ciliated airway cells, possibly revealing new complementary therapies for respiratory infections.

Public health relevance
PROJECT NARRATIVE: The nose is the front line of respiratory defense, and the cells lining the nose are in constant contact with inhaled bacteria and other pathogens. In patients with chronic rhinosinusitis, cystic fibrosis, or diabetes, too much glucose (sugar) in the fluid lining the nasal cavity gives bacteria more nutrients to grow and causes more upper respiratory infections. The goal of this research is to characterize sweet taste receptors expressed in the cells lining the nasal cavity, which we believe could be targeted to reduce nasal fluid glucose and enhance existing treatments for respiratory infections.